Role of Protein N-Myristoylation in Driving DNA Damage Response

PROJECT SUMMARY/ABSTRACT
The DNA damage response (DDR) is crucial for maintaining genome stability, with its dysregulation implicated
in various diseases. Post-translational modifications (PTMs) orchestrate DDR, influencing vital signaling
pathways for genomic stability. N-myristoylation, catalyzed by N-myristoyl transferase (NMT) 1 and 2, has
emerged as a pivotal PTM that involves a range of biological processes. Despite its potential significance, a
knowledge gap persists regarding the role of N-myristoylation in DDR. My preliminary data reveal a link between
reduced N-myristoylation expression and heightened genomic instability. Utilizing quantitative proteomics, 14 N-
myristoylated candidates within key DDR proteins were identified, with four overlapping the interactome of NMT1
and NMT2. Validation studies confirmed N-myristoylation on KU70 and RPA70, the key proteins in the double-
strand break repair. These findings form the basis for the hypothesis that N-myristoylation actively propels DDR
pathways by influencing the dynamics and functions of key proteins pivotal to DDR regulation.
This project systematically investigates the role of N-myristoylation in DDR. Aim 1 delves into the association of
N-myristoylation, modulated by NMT1 and NMT2, with genomic stability and DDR. This includes assessing the
impact of N-myristoylation on DNA repair mechanisms and dissecting the interactome of NMT1 and NMT2 in
response to various DNA damage agents. Aim 2 focuses on the detailed characterization of N-myristoylation on
KU70, including the identification of specific N-myristoylation sites, evaluation of their impact on protein
localization and stability, elucidation of functional consequences in DNA repair, and investigation of regulatory
mechanisms. Transitioning into the R00 phase in Aim 3, I will build upon the insights gained during the K99
phase, leveraging them to validate and characterize additional N-myristoylated DDR candidates identified
through proteomic screening. This phase aims to develop therapeutic implications based on a comprehensive
understanding of N-myristoylation's regulatory role in DDR, enhancing the translational potential of the research.
The successful completion of this work holds the promise of significantly advancing our understanding of the
intricate regulatory networks governed by N-myristoylation in DDR. Beyond scientific contributions, this award
provides comprehensive training in both my technical and professional skills under the guidance of experts in
my mentoring committee, fostering proficiency in the DNA repair field and disease therapy development, thereby
preparing me for the journey of establishing and running a successful independent laboratory.

Public health relevance
PROJECT NARRATIVE This study focuses on protein N-myristoylation, a critical protein modification linked to various diseases, including cancer, epilepsy, Alzheimer's disease, and infections. This study seeks to identify novel molecular targets for therapeutic intervention by delving into the unexplored frontier of N-myristoylation within the DNA damage response (DDR) pathway. The findings could not only advance our understanding of genomic stability but also provide critical insights into the development of precision therapies, potentially revolutionizing the treatment landscape for diseases associated with DDR dysfunction.